A biomarker for personalized care in post-stroke spatial neglect

This SPiRE provides the opportunity to raise the technical expertise of the PI (Barrett), and
provide a critical missing element for personalized rehabilitation care in spatial neglect (SN), a
disabling cognitive deficit causing asymmetric 3-D spatial action, movement, perception and
awareness. For more than 10 years, the PI and colleagues addressed SN by extensively
characterizing neuropsychological deficits, documenting the adverse impact on function and
freedom, and developing feasible SN rehabilitation protocols. Their research reported ~80% SN
underdiagnosis and undertreatment; improving this care delivery gap is certain to reduce the
devastating personal and social losses associated with SN. Here, the PI moves from her past
work advancing dissemination, implementation, and rehabilitation to gain neuroimaging skills
and pursue a new, biological approach to improving SN care delivery. The PI and colleagues
discovered that the Aiming SN subtype, associated with motor-intentional deficits, predicts rapid
improvement of daily life function with early rehabilitation. However, Aiming SN is difficult to
identify on typical behavioral screening. Unlike other SN subtypes, however, Aiming SN is
strongly associated with specific neuroanatomic features: frontal lobe disconnection. In this
study, supported by experts in studying white matter disruption in SN (Carter), white matter
disruption as a predictor of stroke rehabilitation outcomes (Cramer), and novel brain imaging
(Qiu), the PI will develop a new process of SN diagnosis based on brain imaging biomarkers.
The team will develop brain imaging biomarkers associated with Aiming SN, using 4 advanced
imaging procedures, and demonstrate that these biomarkers can predict daily life function
improvement at 3 months and 6 months post-stroke (Aim 1). The experts supporting the PI have
experience with rapidly translating biomarker analyses to clinical imaging data, and thus the
SPiRE will also include a direct comparison of advanced imaging (high-resolution and diffusivity)
versus clinically-acquired data (Aim 2). The team will directly compare the biomarkers derived
from research imaging, with those derived from clinical imaging, to identify Aiming SN. They will
also test the relative ability of research versus clinical biomarkers to predict functional
independence at 3 and 6 months. At the next research step, armed with a potential biomarker
for Aiming SN and for functional gains with SN rehabilitation, our team will propose a larger,
multi-site study for biomarker validation. Our long-term goal is to lead SN research toward
routinely identifying affected veterans, and rapidly providing personalized cognitive
rehabilitation, to improve functional outcomes for veterans with stroke in the community.

Public health relevance
More than 30,000 veterans are hospitalized for stroke each year, and in the critical first months of recovery, at least half are disabled by abnormal 3-D spatial function (spatial neglect). Their self-care, mobility, and ability to return home are severely limited. Worse, many of these veterans are never diagnosed, counseled about the problem, or prescribed spatial rehabilitation. Here, we attempt to speed up spatial neglect diagnosis, using the brain imaging that is always part of the first hours of stroke care. We will compare 4 methods to identify the special brain imaging features present in people with spatial neglect who respond to early rehabilitation, and who recover best at 3 and 6 months after stroke. Once we complete this study, the next step will be to confirm our findings in a larger project, to ensure clinical brain imaging can be used for treatment assignment in veterans across gender, race, and other characteristics.